Impact of aging on metastatic competence of the omentum

Metastasis to the omentum, an immune cell-rich fatty tissue that drapes from the stomach, causes substantial
pain and bowel obstruction. It is difficult to completely resect the omentum and there are no effective strategies
that minimize the risk of colonization of preserved omental tissues by occult cancer cells. Omental metastasis
commonly occurs in women with ovarian cancer who are 60 years of age or older. Findings that ovarian cancer
cells more effectively colonize the omentum of aged mice than young mice strongly implicate that aging
increases metastatic competence of the omentum, but the underlying mechanisms are poorly understood. The
goal of this study is to identify how aging increases metastatic competence of the omentum and develop
strategies that decrease metastatic competence in older females. We recently discovered that a population of
innate-like B cells expands in the uninvolved omentum of mice and women with early-stage ovarian cancer,
and that these cells exert immunosuppressive properties and potentiate omental metastasis. Furthermore, we
identified that innate-like B cells accumulate in the pre-metastatic omentum of young adult mice with ovarian
tumors by homing from the peritoneal cavity. In new studies, we discovered that the normal omentum of aged
females exhibits a striking expansion of innate-like B cells analogous to the pre-metastatic omentum of young
adult females. We therefore hypothesize that heightened metastatic competence of the omentum in aged
females stems from age-related increases in innate-like B cells, and that inhibiting homing of innate-like B cells
to the omentum decreases metastatic competence in aged females. In this study, we will firstly determine
whether heightened metastatic competence of the omentum in aged females stems from increases in innate-
like B cells. Secondly, we will determine whether homing of innate-like B cells to the omentum is increased in
aged females. Thirdly, we will delineate mechanisms that can suppress homing of innate-like B cells to the
omentum in aged females and thereby decrease metastatic competence. These aims will be accomplished by
a combination of approaches that utilize genetically modified mice, adoptive cell transfer, clinical specimens of
human omentum, single cell analysis, and pharmacologic agents. If successful, our study will yield new
mechanistic insights that explain why aging increases metastatic competence of the omentum and valuable
insights into strategies for decreasing the risk of omental metastasis by occult ovarian cancer cells in older
women.

Public health relevance
The majority of ovarian cancer patients who present with omental metastasis are 60 years of age or older. It is difficult to remove the omentum completely and there are no effective strategies that minimize the risk of colonization of preserved omental tissues by occult cancer cells. This project investigates the role of innate-like B cells in age-related omental metastasis, and the possibility that inhibiting recruitment of innate-like B cells to the omentum decreases the risk of omental colonization in older females.